Serotonin Based Therapeutics in Cerebral Palsy

Project Summary: Serotonin based therapeutics in cerebral palsy
Cerebral palsy (CP) is a relatively common nonprogressive disorder causing lifelong motor dysfunction. The most
prevalent type, spastic cerebral palsy, is characterized by muscle hypertonia, weakness, hyperreflexia, less voluntary
(and more involuntary) activation of motor units, thinning of the corticospinal tract, and decreased numbers of motor
units. While weakness and hypertonia in muscles have been well documented in spastic cerebral palsy, the
etiopathogenesis is almost completely unknown.
Previous work and our preliminary data from preclinical models of CP show that motoneurons (MNs) show
excessive activity after perinatal injury, particularly in response to serotonin (5HT). This is likely causing or contributing
to hypertonia since blocking 5HT receptors can alleviate hypertonia. During development, spontaneous neural activity
is largely responsible for establishing connectivity within spinal circuits and between spinal MNs and developing
muscles and establishing numbers of MNs that survive past natural developmental cell death. This proposal focuses
on blockade of spinal 5HT receptors at a critical developmental time point in order to restore normal MN activity /
motor unit function, and alleviate weakness, hypertonia, and hyperreflexia. In this study we will utilize a larger animal
model of CP (prenatal hypoxia-ischemia [HI] at 70-80% gestation in rabbits), which shows robust motor dysfunction
and has recently been demonstrated to have clinical features of CP including thinning of CST and cortical damage,
hyperreflexia, muscle pathology, and reduced numbers of MNs.
Aim 1: Identify postnatal milestones in motor units following prenatal HI injury. From birth to 31 days
of age in rabbit kits of both sexes, we will quantify aberrant development of motor units, specifically 1) motor
behavior in awake kits, including joint torque, 2) in vivo recording of motoneuron / motor unit firing patterns,
motor unit contraction force, and H reflex and 3) anatomical development of motor units. Significance: Timing
of treatment (Aim 3) will be delivered motor unit maturation, either perinatally or postnatally.
Aim 2: Identify 5HT receptor(s) mediating hypertonia. In newborn rabbit kits of both sexes (sham and
HI), we will assess receptor pharmacology and dose dependency in vitro and in vivo using a variety 5HT
receptor agonists and antagonists. Significance: Findings will guide choice of drug treatment in Aim 3.
Aim 3: Evaluate treatment with a 5HT antagonist. We will compare effects of perinatal and postnatal
treatment with a serotonergic antagonist and agonist on sham and HI kits based on results of Aim 2. Treatment
coincides with maturation of motor units. We will examine the outcome in kits as described in Aim 1.
Significance: This aim provides a preclinical evaluation of novel therapeutic for reduction of spasticity in CP.
We will use the rabbit model of CP to evaluate potential therapies to reduce spasticity after prenatal injury.
Several FDA-approved serotonergic drugs could be investigated to improve outcomes in kids at risk of CP.

Public health relevance
Project Narrative: Serotonin based therapeutics in cerebral palsy Cerebral palsy (CP) is a disorder caused by an insult to the developing brain that affects a person's ability to control his or her muscles. Patients often exhibit muscle stiffness, uncontrolled movements, and muscle weakness, but the origin of these symptoms remain poorly understood and treatments are sparse. The aim of this proposal is to evaluate using a serotonergic drug to treat babies at risk for cerebral palsy before their nervous system matures in a dysfunctional way.